Admin Core (Wu)

PROJECT SUMMARY (ADMIN CORE)
All projects and cores in the Program Project will be supported by the Administrative Core. Dr. Joseph Wu will
serve as Administrative Core Leader and will work with the Program Project Executive Committee and the
Internal and External Advisory Boards to provide oversight for the coordination and reporting activities of this
Core. With the assistance of Dr. Aruna Krishnan (Senior Scientist, CVI) and Mr. David Preston (Program
Manager, CVI), the Administrative Core will provide monthly financial status reports to project and core leaders.
The Administrative Core will have the responsibility of organizing regular meetings for project and core leaders
and will be in charge of planning annual workshops which will include all Program Project research personnel
and members of the External Advisory Board. In addition, Mr. Stefan Pavlovic, Grants Administrator for the
Stanford CVI, will work directly with Dr. Wu and have responsibility for fiscal management of the budgets and
budget reporting. He will serve as liaison for financial aspects of the subcontracts with UC Davis. Travel costs
for the External advisors to attend these annual meetings at Stanford are centralized in this core. The cost of
travel for grant personnel to attend two group meetings per year (one at Stanford and one at Sacramento) are
also centralized in this Administrative Core. This core will also oversee all aspects of visits by consultants and
seminar speakers.

Public health relevance
PROJECT NARRATIVE (ADMIN CORE) This Program Project Grant (PPG) will define new pathways in mechanism, prognosis, and drug response in heart failure (HF) patients. This will be achieved through multidisciplinary analysis of human induced pluripotent stem cell-derived cardiomyocytes (iPSC-CMs) from a large cohort of HF patients (Projects 1 & 3). This will be followed by novel investigation into precise cellular mechanism of electro-mechanical dysfunction in animal models (Project 2). We will then use high throughput drug testing to determine arrhythmic risk of given genotype variants. The Administrative Core will provide administrative services (financial management and organization) to all of the Projects and Core B in the PPG.